Multimodal omics approach to identify health to cardiometabolic disease transitions

Abstract: The global obesity epidemic drives the high prevalence of cardiometabolic disorders (CMDs),
including type 2 diabetes (T2D), and non-alcoholic fatty liver disease (NAFLD). Epidemiological studies have
also established strong sex differences in CMDs. Obesity-induced low-grade inflammation and insulin resistance
in adipose tissue (AT), their deteriorating impacts on the efficacy of adipogenesis, and subsequent ectopic fat
storage into other cardiometabolic tissues, particularly liver, have been proposed as the key drivers of the CMD
risks related to obesity. However, the mechanisms promoting the transitions from health-to-disease states in
human fat depots have remained largely elusive. We hypothesize that there are transcriptional inflammatory
markers and cell-type-specific changes in open chromatin pertinent to health-to-CMD transitions that can be
discovered using single cell level and bulk omics analyses in fat cell-types and tissue. We also hypothesize that
by elucidating molecular responses to obesity-related stimuli during adipogenesis we can discover candidate
variants and genes with functional priors for formal identification of gene-sex and gene-environment interactions
(i.e. GxSs and GxEs) underlying obesity-induced health-to-CMD transitions in large biobanks. In Aim 1, we will
generate sex- and context-specific bulk and single cell level transcriptomics (RNA-seq) and epigenomics (ATAC-
seq) data in two obesity-relevant fat depots, i.e. subcutaneous and visceral AT, to identify epigenetic and
transcriptional markers for health-to-CMD transitions in six health-to-CMD stages comprising lean, overweight,
and obese males and females with and without prediabetes, T2D, and NAFLD. We will also use existing serum
samples to discover health-to-CMD transition biomarkers among the genes that differ between the six
health/disease states and encode secreted proteins. We will test the top results for replication in independent
omics cohorts, including Mexicans. In Aim 2, we will use a new function-to-variants omics approach to discover
GxSs and GxEs involved in early transitions from health to CMD in males and females. We will generate
functional genomics data in CMD-relevant human primary preadipocytes, extracted from fresh AT of normal
weight, metabolically healthy males and females. These preadipocytes will be differentiated with and without key
inflammatory stimuli to discover stimuli-responsive adipogenesis genes and cis-regulatory elements (CREs) that
harbor regulatory variants in diverse populations. Subsequently, these variants will be fine-mapped using
massively parallel reporter assay in (pre)adipocytes and functionally characterized using extensive variant-to-
gene-linkage analysis and genomic perturbations (CRISPR and siRNA). The identified candidate SNPs will be
tested for GxE and GxS effects on health-to-CMD transitions in large biobanks to verify their role in these critical
transitions. Our preliminary results and ample previous experience with integrative multiomics approaches of
CMDs provide a strong prior scientific rigor for the proposed Aims, and overall, accomplishing our Aims has a
great potential to develop personalized strategies that prevent or postpone the onset of obesity-related CMDs.

Public health relevance
PROJECT NARRATIVE Despite the on-going serious obesity epidemic, genetic factors, gene-environment and gene-sex interactions as well as biological mechanisms driving obesity-related health-to-disease transitions towards manifestation of obesity-induced cardiometabolic disorders (CMDs) have remained largely elusive, leaving a significant number of individuals without proper prevention and care. To address these pressing medical knowledge gaps, we propose to 1) elucidate epigenetic and transcriptional markers for health-to-cardiometabolic disease transitions in males and females; and 2) discover gene-environment and gene-sex interactions for health-to-CMD transitions using a new function-to-variants omics approach and its follow-up in extensive biobanks. Overall, our health-to- CMD approach has a great potential to help prevent CMDs and delay their onset.